The Mitochondrial Calcium Uniporter in Pancreatic Cancer Development, Metastasis, and Treatment

Summary:
Pancreatic adenocarcinoma (PDAC) is a particularly lethal form of cancer which kills over 40,000
Americans every year. PDAC is most often diagnosed when disease is advanced, with apparent
metastases that often lead to death. Patient outcomes are further negatively impacted by a
typically poor response to currently available treatments. It is thus critical to develop a stronger
understanding of the processes which lead to PDAC development and metastasis, as well as to
determine novel, more efficacious targets for therapies. We hypothesize that the mitochondrial
calcium uniporter (MCU), a mitochondrial membrane ion channel, may contribute to cancer
development, metastasis, and tumor maintenance, and may therefore present a viable anticancer
target. This protein is required for the low-level, constitutive transfer of Ca2+ from the endoplasmic
reticulum to the mitochondria that cancer cells appear to be dependent upon for survival. Previous
studies have been hampered by the lack of suitably selective, cell-permeable pharmacological
agents to block this pathway. We thereby propose to examine the role of MCU in PDAC
development, metastasis, and tumor maintenance through the use of genetic approaches and
novel animal and cell culture models. We will use genetic editing techniques, such as the Cre/lox
and CRISPR/Cas9 systems, to observe the role of MCU in these processes. We will knock out
MCU during early development in the murine genetic model of PDAC, the KPCY mouse, to
observe the role of this protein in tumor development. We will also assay proliferation, cellular
metabolism, oxygen consumption rates, and mitochondrial calcium flux (via electrophysiology and
mitochondrial calcium uptake assays) in cell lines and 3D cultures generated from this model, as
well as patient-derived cell lines and the established human PDAC cell line, Panc-1. We will re-
express MCU in the knockout cells, and we will use CRISPR/Cas9 to knock out MCU in MCU
wild-type cells to ensure effects are MCU-dependent. To observe the role of MCU in metastatic
colonization, we will use a tail-vein metastasis model with Panc-1 cells expressing luciferase in
NOD/SCID mice, as well as transwell invasion, gel degradation assays, and Western blotting for
metastasis-associated markers of epithelial to mesenchymal transition, such as cadherins and
matrix metalloproteases. We will also quantify metastasis from the KPCY model using the YFP
reporter gene. To observe the role of MCU in tumor maintenance and thus establish its therapeutic
potential in more advanced disease, we will use an inducible CRISPR/Cas9 knockout cell culture
model of murine PDAC in vitro and an orthotopic model to observe the effects of acute MCU
ablation in already growing tumors and cells as a method to simulate pharmacological inhibition.
These studies will elucidate the role of MCU in PDAC development, metastasis, and maintenance.
Significantly, the findings resultant from this work may inform future development of screening
methods or treatment modalities in PDAC, potentially saving lives.

Public health relevance
Narrative: This project will use animal and cell culture models to identify the role of a mitochondrial membrane protein, the mitochondrial calcium uniporter, in development of pancreatic cancer and its metastasis. These studies may lead to treatments to significantly improve patient treatment paradigms for this highly lethal disease.